Integrating polygenic and environmental risk factors for asthma in diverse populations

Project Summary/Abstract
Asthma is a complex, inflammatory airway disease that affects millions of people worldwide with striking health
disparities. The relatively high heritability of asthma suggests that genetic factors contribute substantially to
asthma risk. Our understanding of these genetic risk factors has rapidly expanded in just the past few years, with
large-scale genome-wide association studies (GWAS) collectively identifying hundreds of common genetic
variants associated with asthma. The wealth of information coming from these studies suggests that genetics
may improve asthma risk prediction models, which may be useful in intervention, prevention, and targeted
disease management strategies. However, existing models currently have modest clinical potential and primarily
draw from only a handful of personal, family, and environmental variables. Therefore, we propose to apply
statistical approaches to assess the utility of (a) quantitative indexes of genome-wide genetic risk and (b)
aggregated environmental risk exposures, individually and combined, for predicting asthma case status in
populations of different ancestries. Specifically, in Aim 1, we will derive polygenic risk scores (PRS) for asthma
from the largest and most diverse GWAS of asthma to date. In Aim 2, we will develop asthma PRS that leverage
genetic information from correlated diseases and traits. In Aim 3, we will utilize phenome-wide approaches to
select and collate environmental exposures relevant to asthma risk from a rich phenotypic resource, with the
ultimate goal of building an integrated risk model that considers genetic and environmental risk factors across
diverse populations. These Aims will provide insights into the predictive potential of these comprehensive
models, as well as tools for constructing PRS and environmental risk scores for asthma in populations
underrepresented in genomic studies. Together, the analyses will facilitate the development of more accurate
population-based risk prediction tools for asthma. The proposed research will provide the fellowship PI with a
rich training experience in the Harvard PhD Program, the Broad Institute of MIT and Harvard, and the
Massachusetts General Hospital. With the mentorship of her sponsors and collaborators, she will achieve several
training goals that will lay the foundation for her development as an independent researcher and ultimately, a
principal investigator.

Public health relevance
Project Narrative Asthma is a major global health burden, yet research on the potential utility of large-scale genome-wide and phenome-wide approaches for asthma risk prediction remains limited. This project proposes to apply statistical methods to develop integrated models of asthma risk with polygenic and environmental risk predictors in diverse populations. These analyses will advance our understanding of genetic and environmental contributions to asthma risk and provide novel approaches for studying asthma across populations.